Targeting cellular senescence to prevent epileptogenesis

Project Abstract
Epilepsy is a chronic neurological condition characterized by recurrent seizures, affecting 65 million individuals
and is recognized as a comorbidity in several neurodegenerative diseases, including Alzheimer’s disease (AD).
Identifying targets to prevent the development of epilepsy (i.e., epileptogenesis) is a large unmet need.
Antiepileptogenic therapies remain limited, even in preclinical models. Here, we propose to examine a novel
target, senescent cells (SCs) in the brain, to determine if ablating these cells can prevent epileptogenesis in the
pilocarpine mouse model of temporal lobe epilepsy and in the APdE9 mouse model of AD with comorbid
epilepsy. Cellular senescence is a conserved cellular program which halts proliferation and triggers a pro-
inflammatory senescence associated secretory phenotype (SASP) in response to damaging stimuli. SCs are of
growing interest in neurodegenerative diseases but remain completely unexplored in the context of epilepsy.
Epileptogenic insults, such as status epilepticus (SE) robustly trigger DNA damage, a common cause of cellular
senescence. Moreover, the pro-inflammatory cytokine profile reported during epileptogenesis shares striking
similarities to the SASP. We will use the INK-ATTAC mouse model, which selectively expresses an inducible
suicide gene (and GFP) under the control of the p16 promoter; p16 expression is a hallmark of SCs. In Aim 1,
we will first determine the cellular identity (glial, neuronal) of p16 positive cells following pilocarpine-induced SE.
We will next determine if ablating SCs reduces proinflammatory cytokine expression after SE. Finally, we will
determine if ablating SCs reduces the development of spontaneous seizures and/or reduces expression of
seizures once they occur. In Aim 2, we will target a model with a different etiology, the APdE9 mouse model of
AD, which displays co-morbid seizures, and accumulation of SCs. As in Aim 1, we will first characterize the
cellular phenotype of SCs in the APdE9 model. We will next determine if ablation of SCs reduces proinflammatory
cytokine levels in APdE9 mice. Finally, we will determine if ablation of SCs reduces spontaneous seizure
occurrence in APdE9 mice. By using two models, with very different etiologies and “clinical” presentation
(convulsive seizures after pilocarpine, non-convulsive seizures in the APdE9 model), we are positioned to test
the overarching hypothesis that SCs contribute to the emergence of spontaneous seizures during
epileptogenesis, as compared to an effect that is specific to only a particular model. Cellular senescence is
unexamined in epilepsy, thus, these studies have the potential to open new lines of research into the
mechanisms of epileptogenesis.

Public health relevance
Project Narrative Cellular senescence is a conserved program which prevents damaged cells from proliferating, but is associated with inflammation and can trigger brain dysfunction. Removing senescent cells rescues brain function in models of neurodegeneration, but it has not been explored in epilepsy. We will determine if senescent cells contribute to these dysfunctions in a model of acquired temporal lobe epilepsy and in a model of Alzheimer’s disease associated epilepsy by ablating senescent cells, potentially opening a new treatment avenue to prevent the development of epilepsy.